Developing multi-cue piezoelectric PVDF-TrFE biomaterials for peripheral nerve repair

PROJECT SUMMARY
Peripheral nervous system (PNS) injuries impact millions of Americans each year with
approximately 20 million people currently living with the effects of such injury. In the case of
severe injuries, nerve pathways, connections, and the extracellular matrix (ECM) surrounding
the nerve that lead to the distal innervation targets are disrupted. If the injury gap is large
enough, functional recovery is extremely limited and adequate clinical therapies don’t exist. A
key reason for poor functional recovery is that neurons lack the proper guidance, alignment, and
signaling from the damaged ECM to allow for targeted growth across injured tissue. Therefore,
our overarching goal is to develop an ultrashock-mediated, bioactive scaffold to address
traumatic PNS injury. The scaffold will possess controllable electrical, physical, and chemical
signaling capabilities to address guidance, alignment, and cell-ECM communication.
Piezoelectric poly(vinylidene fluoride-co-trifluoroethylene)(PVDF-TrFE) is integrated with
decellularized ECM and capable of producing controllable electrical stimulation in response to
remote ultrashock activation without the need for electrodes due to its piezoelectric capacity.
The studies proposed will focus on quantitatively determining and controlling the electric
potential of the scaffolds due to ultrashock and mechanical stimulation (Aim 1), analysis of the
integration and phenotypic response of Schwann cells to PVDF-TrFE scaffolds (Aim 2), and the
ability of the scaffold to minimize immune response while evaluating the ability to repair critical
sized nerve gaps in vivo (Aim 3).

Public health relevance
PROJECT NARRATIVE Traumatic peripheral nervous system injuries have a devastating impact on patient quality of life and currently lack therapies for consistent functional recovery. The proposed project will develop and demonstrate the feasibility of an ultrashock-mediated, biocompatible, piezoelectric scaffold integrated with integrated bioactivity. The scaffold will transmit the necessary electrical, physical, and chemical signals to initiate and improve cell-biomaterial interactions, minimize the immune response, and facilitate peripheral nerve regeneration in critical injury gaps.